A novel approach for prevention of Bronchopulmonary dysplasia in at-risk pre-term infants

ABSTRACT
Bronchopulmonary Dysplasia (BPD) is the most common chronic respiratory disease in infants and is a
devastating condition that disrupts the developmental program of the lung secondary to preterm birth. BPD
affects neonates exposed to mechanical ventilation and, to date, there are no specific drugs available to prevent
or treat this life-threatening condition. The pathologic hallmarks of BPD are hyperoxia-induced pulmonary
inflammation, increased cell death, dysregulated angiogenic factors culminating in impaired alveolarization,
dysregulated vascularization of the lung and pulmonary hypertension. AyuVis Research, Inc, is developing a
novel class of low molecular weight natural oligosaccharide-derived small molecules which activate macrophage
to a non-inflammatory phenotype via TLR4 signalling. In both mouse and preterm lamb BPD models, the lead
candidate AVR-48 binds to TLR4 resulting in selective activation of the target cell to block inflammatory mediators
in lung and upregulation of endogenous vascularization pathways improving lung vascularization/alveolization
leading to improved lung function. Additionaly, it enhances production of certain host anti-inflammatory molecule
such as IL-10 and growth factor VEGF with vascularization effects remaining local to lungs. AVR-48 also
prevents the development of BPD associated pulmonary hypertension. We have demonstrated all these above
mentioned therapeutic effects in two BPD models: intraperitoneal injection of AVR-48 prevents hyperoxia-
induced BPD in a neonatal mice pup model at 10mg/kg dose and intravenous injection in invasive mechanical
ventilator induced BPD in pre-term lambs at 3.0 mg/kg dose. In order to advance the lead candidate AVR-48,
AyuVis is proposing three complimentary aims: (1) Determine safety and long-term efficacy in the preterm lamb
model by testing whether prophylactic treatment with AVR-48 improves the long-term respiratory, cardiac and
neurodevelopmental outcomes measured after 2 months of life to mimic 1-2 years of infant life; (2) Demonstrate
anti-inflammatory effect of AVR-48 in human cord blood after LPS and hyperoxia challenges by measuring
cytotoxicity, inflammatory and anti-inflammatory mediators and macrophage phenotypes (M1, M2, M1/M2); and
(3) Determine toxicokinetic parameters in juvenile rats following GLP protocol that will be used to model human
equivalent dose in clinic. These studies are expected to provide mechanistic and confirmatory efficacy data
which would enable AVR-48 to progress to GMP manufacturing and file an Investigational New Drug application
with the FDA.

Public health relevance
NARRATIVE Bronchopulmunary Dysplasia (BPD) is a disease of pre-term infants whose lungs are injured upon exposure to excess oxygen from ventilators, impairing effective gas exchange in the lungs. Ayuvis Research is developing a novel class of immunomodulating compounds derived from chitin that decrease inflammation and improve lung vascularization as well as decrease pulmonary hypertension. Our objective is to test the efficacy of our lead compound in pre-term lamb model mimicking the physiology of ventilated preterm human infants and to further validate its effect in a series of animal and in vitro tests. Results of this research will lead to much needed prophylactic treatment for BPD and treatment for other life-threatening lung conditions.